Integrative analysis of multi-omics data to identify and characterize long noncoding RNA-derived fusions in pediatric cancer

Cancer remains the leading cause of death by disease past infancy among children in the United States. In
contrast to adult cancer with many genetic mutations, most pediatric cancers have few genetic mutations. Instead,
recent studies have shown that fusion RNAs and their encoded proteins may drive tumorigenesis in children.
Fusion RNAs are generated by exons from two genes. With the launch of the Fusion Oncoproteins in Childhood
Cancers Consortium, more fusion proteins are being found and studied. However, a complete understanding of
the mechanisms in pediatric cancer remains elusive, mainly due to three unsolved challenges. First, current
studies have focused on mRNA-derived fusion proteins and have not explored long noncoding RNA-derived
fusion transcripts (lnc-fusions) and their encoded proteins in pediatric cancer; although lnc-fusions have been
reported in adult cancer to regulate anti-tumor immunity. long noncoding RNAs (lncRNAs) are long transcripts
of at least 200 nucleotides that cannot encode protein. lncRNAs largely outnumber mRNAs and play critical roles
in various cancers. Therefore, a complete investigation of mechanisms driving pediatric cancer is not possible
without expanding the study of fusion proteins to include lncRNA-fusions. Second, existing lnc-fusion detection
methods cannot explore lnc-fusions that are derived from novel lncRNAs. Due to high disease-specificity, most
lncRNAs have not been annotated in pediatric cancer. Third, fusion RNAs, including lnc-fusions, may be formed
by alternative mechanisms, such as chromosome rearrangement or aberrant splicing events. These alternative
mechanisms complicate the understanding of genetic mechanisms and thus treatment.
The large amount of multi-omics data from various Common Fund sources enables us to address these
challenges in pediatric cancer. Previously, we had developed computational methods to identify and characterize
lncRNAs for human diseases and development. To discover molecular drivers in pediatric cancer, we will extend
our previous studies of lncRNAs to identify lnc-fusions from RNA sequencing data (Aim 1). We will further
determine the potential functions and formation mechanisms of lnc-fusions using integrative methods (Aim 2).
Machine learning algorithms will be used to identify lnc-fusions as putative biomarkers and prognostic biomarkers
in pediatric cancers.
This study will focus on neuroblastoma and myeloid malignancies since these pediatric cancers have
large cohorts of RNA sequencing and whole-genome sequencing data in the Gabriella Miller Kids First Dataset.
In summary, we will discover lnc-fusions in pediatric cancers, develop computational methods and
frameworks broadly applicable to existing and future RNA sequencing datasets. This study will improve the utility
of three selected Common Fund datasets (Kids First, GTEx and 4DNucleome), and two external databases
(GEO and TCGA).

Public health relevance
Fusion RNAs and their encoded proteins are widely found in various cancers and have been used as biomarkers and therapeutic targets for multiple cancers. However, long noncoding RNAs (lncRNAs) derived fusion RNAs (lnc-fusions) have been largely ignored, especially in pediatric cancer. This study will integrate machine learning and computational approaches to identify and characterize lnc-fusions in pediatric cancer using multi-omics data from the Common Fund Datasets (Gabriella Miller Kids First, GTEx, and 4DNucleome) and external databases (GEO and TCGA).